Postdoctoral Training Program in Trauma

Project Summary
The University of Texas Health Science Center at Houston (UTHealth) seeks a fourth renewal of its successful
multidisciplinary postdoctoral Ruth L. Kirschstein National Research Service Award (NRSA) Institutional
Research Training Grant (T32) in injury and critical illness. The goal of this training program is to provide
multidisciplinary research training for postdoctorates in trauma to develop future independent investigators who
will use these skills in academic careers that increase understanding of the mechanisms of traumatic injury and
subsequent critical illness and to inform clinical practice. To accomplish these goals, our program recruits and
selects postdoctoral candidates who are interested in pursuing an academic career in trauma-related research
each calendar year for two-year positions. At the end of the two years of training, each fellow is able to: 1)
critically analyze available published data; 2) formulate a focused hypothesis; 3) design and perform necessary
experiments to test the hypothesis; 4) analyze and interpret results to draw appropriate conclusions and
potentially modify experimental strategies; 5) effectively present the results of their research both orally and in
writing; and 6) prepare a competitive research proposal. Over 15 years, 52% (10/17) of fellows who completed
their training (T32 and subsequent) are currently in academic positions, and 41% have been awarded
independent funding; 208 manuscripts have resulted from the award over the past 10 years. Since its creation
in 2001, this T32 training program has evolved, and we propose new elements and faculty to advance and focus
our training efforts. In the proposed Program Plan, we expand our focus to the following areas in injury and
critical illness: Traumatic Brain Injury; Hemorrhage Control and Resuscitation; Inflammatory Consequences and
Organ Dysfunction; Cell Therapy; and Bum with each fellow receiving instruction in responsible conduct of
research, reproducibility, epidemiology, biostatistics, and informatics in concert with their career goals and
Individual Development Plan. Dr. Charles Cox remains the Program Director of the training program, and he is
assisted by a newly added Assistant Director and a Program Manager to form the Steering Committee. The
leadership receives guidance from an External Advisory Committee, including a sub-committee to enhance
diversity. Each trainee is assigned 1 of 10 Primary Faculty Mentors who bring varied expertise and vast
mentoring experience and are responsible for ensuring that fellows receive appropriate training to design
effective, ethical, and informative research projects. Resource Faculty members are also available to assist in
project execution in areas of expertise different from Primary Mentors. Lastly, expanded evaluation procedures
are proposed to improve the training experience for both mentors and trainees. This comprehensive approach
ensures that a well-rounded, diverse faculty will assist and guide these young scientists along the path to
academic independence and significant future contributions to the care of injured patients.

Public health relevance
Project Narrative Trauma is the leading cause of death in people from 1-44 years and the leading cause of life years lost. The proposed renewal T32 program will provide support for postgraduate research training in injury and critical illness in the Department of Surgery at McGovern Medical School at The University of Texas Health Science Center at Houston. The goal of this training program is to provide a cohort of future clinical and translational scientists to increase basic and clinical understanding of trauma-related illness and improve the outcomes of injured patients.